Targeting cytochrome bd as an anti-biofilm strategy

SUMMARY
Significance: Urinary tract infection (UTI) is among the most prevalent urologic diseases, and it is caused
primarily by uropathogenic Escherichia coli (UPEC). Bladder infection by UPEC is characterized by a transient
intracellular stage during which bacteria invade superficial epithelial (facet) cells and divide within the cytosol to
form multicellular communities called biofilms. After replicating in the cytosol, bacteria exit the intracellular biofilm
– killing the bladder epithelial cell in the process – and disseminate to naïve facet cells or to the upper urinary
tract. While in the intracellular biofilm state, bacteria evade innate immune responses and the effects of
antibiotics. Similarly, in catheterized individuals, formation of biofilm on the catheter surface creates an additional
protective niche for UPEC, from which it can disseminate to the bladder and seed infection. The goal of this
proposal is to evaluate the potential of inhibiting biofilm by interfering with UPEC respiration.
Rationale and Hypothesis: Although UPEC are facultative anaerobes, they respire oxygen during infection in
the hypoxic bladder environment. Aerobic respiration and oxygen sensing have also been linked to the
expression of critical UPEC virulence factors. We have previously shown that aerobic respiration is essential for
UPEC to establish infection. Of the three respiratory quinol oxidases encoded by UPEC, cytochrome bd has the
highest affinity for molecular oxygen, exceeding the affinity of mitochondrial cytochrome c by 1000-fold. Deletion
of the cydABX genes that code for cytochrome bd, does not impart a growth defect in vitro, but leads to significant
alterations in UPEC biofilm architecture, leading to higher susceptibility to antibiotics in the biofilm state.
Furthermore, cydABX deletion mutants are non-motile, exhibit decreased proton motive force (pmf) and are
attenuated in a murine UTI model. Finally, deletion of cydABX results in increased expression of the low affinity
quinol oxidase cytochrome b0. We hypothesize that cytochrome bd can be chemically targeted to thwart
biofilm formation or dissemination from a pre-formed biofilm. We further posit that cytochrome bd has
a role in energizing motility. We propose two aims to test the posed hypotheses:
Aims: Aim 1 will will evaluate whether targeting of cytochrome bd using known cytochrome bd inhibitors can
enhance antibiotic effectiveness. Aim 2 will determine whether the decreased membrane potential of the
cytochrome bd mutant imparts generalized or specific effects on pmf-dependent processes and determine how
these impaired processes affect motility. Finally, using chemical inhibition of cytochrome bd we will evaluate
whether loss of cytochrome bd function impairs dissemination from the biofilm.
Impact: These studies will be the first to address the unique contribution of cytochrome bd on UPEC motility and
will determine whether targeting bacterial respiration is a viable therapeutic or prevention strategy against UTI.

Public health relevance
NARRATIVE Urinary tract infection (UTI), one of the most prevalent bacterial infections, is caused primarily by uropathogenic Escherichia coli (UPEC) and it is recalcitrant to treatment due to the ability of UPEC to form biofilms on catheters and host cells. The work proposed in the attached application expands on our recent findings demonstrating that UPEC uses the high-affinity quinol oxidase cytochrome bd to respire aerobically during infection and that deletion of cytochrome bd alters UPEC biofilm susceptibility to antibiotic treatment. In collaboration with Vanderbilt’s institute for chemical biology, we propose the use of synthesized cytochrome bd-specific inhibitors to evaluate the potential of preventing the establishment of UPEC biofilms on catheter material (aim 1) or, altering the architecture of pre-formed biofilms to increase the efficacy of antibiotics (aim 2).